Endoplasmic Reticulum Stress in Neurodegeneration

Tauopathies are devastating neurodegenerative diseases that impair cognition, memory, movement, strength,
and vision. Tauopathies are caused by the accumulation of misfolded pathologic tau protein in affected brain
regions. Tauopathies like Alzheimer's Disease affect millions of aging Veterans. Tauopathies also affect
younger Veterans who develop Chronic Traumatic Encephalopathy after repeated blast exposure head
trauma. The Veterans Health Administration expends significant resources supporting tauopathy patients, but,
there are no cures. These diseases are all fatal. Therefore, there is a critical need to identify ways to treat
these patients and to prevent functional debilitation arising from tauopathy neurodegenerations. In this VA
Merit award, we investigated a recently discovered genetic risk factor for tauopathies: EIF2AK3/PERK.
EIF2AK3/PERK encodes a protein kinase that prevents protein misfolding in cells. We found that patient stem
cell-derived neurons carrying EIF2AK3/PERK tauopathy variants showed reduced kinase activity, increased
tau pathology, and increased vulnerability to stress-induced cell death. Last, we found that small molecule
activation of EIF2AK3/PERK signaling reduced tau protein pathology in vitro. Based on our findings, we
hypothesize that EIF2AK3/PERK determines tauopathy neurodegeneration risk in people by regulating tau
protein pathology and neuronal vulnerability to ER stress. Furthermore, our data reveal an exciting, new
strategy to treat tauopathy by pharmacologically enhancing EIF2AK3/PERK signaling. To advance and
translate our findings from the prior funding period, in our renewal application, we propose preclinical studies to
evaluate neurologic function outcomes after genetic or pharmacologic enhancement of EIF2AK3/PERK
signaling in mouse models of tauopathy neurodegeneration. Our 3 specific aims for the renewal application
are: Specific Aim 1. Test how genetic enhancement of EIF2AK3/PERK affects disease onset, progression,
and survival in preclinical mouse model of tauopathy neurodegeneration. Specific Aim 2. Evaluate therapeutic
potential of orally bioavailable phosphatase inhibitors in tauopathy mice. Specific Aim 3. Characterize
proteostatic properties of new small molecule activators of EIF2AK3/PERK pathway. In the animal studies, we
will employ the PS19 tauopathy mouse model that expresses human misfolded tau in the mouse nervous
system and develops phenotypes similar to human tauopathy diseases. We will perform batteries of
behavioral tests to measure neurologic function with respect to cognition, memory, locomotion, strength, and
vision after genetic or pharmacologic treatments. We will also track animal survival after genetic or
pharmacologic modulation of EIF2AK3/PERK pathway. In the drug screening studies, we will quantify tau
protein aggregation in dose-response studies after small molecule treatment using biochemical and cellular
assays to identify new “top hit” compounds that reduce tau pathology based on targeting the EIF2AK3/PERK
pathway. These studies will provide essential preclinical data about using restoring neurologic function
through this signaling process. These studies will generate novel intellectual property and treatments in the
form of small molecule agents that reduce tau protein pathology. Tauopathies are devastating diseases that
affect many Veterans. Treatments are lacking. Our studies directly relate to the objectives of RR&D by
identifying new ways to maintain vital neurologic functions – cognition, memory, locomotion, strength, and
vision – in aging Veterans, Veterans with repeated head trauma injuries, and Veterans with tauopathy
neurodegenerative diseases. Our studies will benefit the mission of the VA by identifying new drug treatments
to prevent neurodegeneration in Veterans especially those carrying genetic risk factors.

Public health relevance
Tauopathies are devastating neurodegenerative diseases that impair cognition, memory, movement, strength, and vision. There are no cures, and all tauopathy diseases are fatal. There is a critical need to identify ways to treat tauopathy patients and to prevent functional debilitation arising from tauopathy neurodegenerations. In this VA Merit award, we test an exciting, new strategy to treat tauopathy by enhancing EIF2AK3/PERK signaling, based on our prior findings that this pathway significantly increased risk for developing tauopathy neurodegenerations when defective in patients. We will evaluate neurologic outcomes and survival in preclinical animal models after genetic or chemical EIF2AK3/PERK activation. We will also characterize new small molecule EIF2AK3/PERK chemicals as potential drugs to combat tauopathy. Our studies will benefit Veterans by identifying new drug treatments to maintain healthy brain function and prevent neurodegeneration especially those carrying genetic risk factors.